The Role of Immature Tumor Subpopulations In Pediatric Rhabdomyosarcoma

PROJECT SUMMARY / ABSTRACT
Rhabdomyosarcoma (RMS) is a devastating pediatric soft tissue cancer with morphological features of develop-
ing skeletal muscles. Although most patients with RMS achieve a complete remission, one third will develop
disease recurrence which is associated with a dismal clinical outcome. These clinical challenges underscore an
urgent need to identify patients at risk for resistance and develop better therapy to reduce the risk of recurrence.
Our pilot study revealed that rhabdomyosarcoma tumors have developmental intratumoral heterogeneity: differ-
ent cells in a single tumor harbor transcriptomic feature of different myogenic stages. Moreover, tumor cells with
developmentally immature characteristics are enriched in post-therapy specimens and have the potential to rep-
licate and reconstitute the entire developmental trajectory after therapy. In this application, we will develop com-
putational analysis methods to unambiguously identify immature tumor subpopulations in single cell RNA-seq
data and to reveal their master deregulated genes (Aim 1); In Aim 2, we will characterize the changes in those
transcriptional networks and cellular states during treatment in orthoptic patient derived xenograft models (O-
PDXs) in vivo. And in Aim 3, we will develop an innovative deep-learning data mining approach to evaluate the
prognostic significance of the myogenic transcriptional networks that underly RMS cellular heterogeneity in pa-
tient tumors. The proposed study integrates computational, statistical and experimental approaches to study the
role of immature cell populations in rhabdomyosarcoma recurrence. Building upon our computational expertise,
research experience in rhabdomyosarcoma, robust preliminary results and highly productive collaborations with
multi-disciplinary expertise in genomics/epigenomics, machine learning, Bayesian statistics and translational re-
search in rhabdomyosarcoma, we are in a unique position to achieve the goals of this research proposal. The
proposed research will be impactful because it will potentially change how we treat children with rhabdomyosar-
coma and the developed computational/statistical approaches will be broadly applicable to cancer research.

Public health relevance
PROJECT NARRATIVE Tumor relapse is a major clinical challenge for patients with rhabdomyosarcoma. The goal of this interdisciplinary proposal is to combine single-cell omics profiling, computational, statistical and experimental approaches to identify immature subpopulations in rhabdomyosarcoma samples, to investigate the effect of chemotherapy on selection for immature cells and to establish predictive promoter/enhancer activity markers of immature cells for analyzing clinical samples.